186-RE (SN) HEDP FOR IV INJECTION IN DIAG. &TREAT. OF METASTATIC CARCINOMA TO BO

186-Re-(Sn)-HEDP is an entirely new agent developed at the University of Cincinnati for the treatment of osteometastases to bone.